Develop RAMAN imaging to visualize metabolism in cell lines and tissue

In this project, we are now combining Raman-based methods with machine learning and other tissue imaging modalities to understand the contribution of different components of the tumor microenvironment that support the lipid needs of oligodendroglioma by using tissue from patients. We will also use these methods to decipher the mechanism of action of potential inhibitors. I have initiated a collaboration with Dr. Ion Petre from the University of Turku in Finland to utilize his lab's expertise in developing machine-learning approaches for our Raman spectra. Our preliminary study using tissue from 46 patients has demonstrated the power of this machine-learning approach. We showed that there are major differences between IDH1mut and IDH1WT tumors in their fatty acids, phospholipids, and cholesterol esters.